Investigating molecular and cellular mechanisms of SCLC development to identify novel therapeutic strategies

SUMMARY
My laboratory has been interested in the mechanisms that control the identity and the fate of cancer cells
during tumor evolution, including in response to treatment. We have made important contributions to this field
of research in the past decade. Our work on the retinoblastoma tumor suppressor Rb in stem cells and cancer
models has identified a new function role for Rb in the control of cell identity and plasticity, which explains in
part why Rb-mutant cancer cells often fail to respond to therapy. Our pioneering work on Rb-mutant small cell
lung cancer (SCLC) has provided fundamental novel insights into the biology of this neuroendocrine cancer.
SCLC is the most lethal form of lung cancer. Treatment options have remained virtually unchanged for the
past 30 years. SCLC kills ~250,000 patients worldwide every year. As the number of heavy smokers worldwide
continues to grow, SCLC will remain a major health issue this century. With unique tools to study SCLC in vivo
and a highly resourceful network of collaborators, we are uniquely placed to continue to greatly impact the
SCLC field by confronting key issues that few investigators address. Importantly, our research combines
technically innovative approaches that will allow us to address questions about SCLC progression and
maintenance that are difficult, if not impossible, to tackle using traditional human tumor-derived cell lines,
previous mouse models, or cancer patient samples. We have developed rapid and accurate mouse models of
human SCLC. We have used these models and patient-derived xenografts to identify the cell of origin of SCLC
and biomarkers for early detection, as well as drivers of the tumorigenic phenotype of SCLC and their
mechanisms of action. We have also contributed to the elucidation of the genomic landscape of mouse and
human SCLC tumors. Notably, our findings have led to the implementation of clinical trials in SCLC patients.
In the next 7 years, we will continue to use SCLC as a paradigm to elucidate the mechanisms that
determine the identity of cancer cells, their plasticity, and their fate. We will perform these studies in the context
of our recent breakthroughs investigating inter- and intra-tumoral heterogeneity in primary mouse and human
SCLC tumors. Our model is that SCLC tumors, which have very few stromal cells, generate their own
microenvironment to support their growth, in part through activation of Notch signaling. This intra-tumoral
heterogeneity may critically contribute to the lack of response of tumors to therapies. A second major focus of
our work is to elucidate the mechanisms that underlie the striking metastatic ability of SCLC to multiple organs,
including the brain. We propose that the switch to a more neuronal differentiation state that accompanies the
gain of metastatic ability of neuroendocrine SCLC cells is a key aspect of this high metastatic potential. We will
test these ideas in vivo and ex vivo using a combination of unique genetic, molecular, and cellular approaches.

Public health relevance
NARRATIVE We investigate the molecular and cellular mechanisms of small cell lung cancer (SCLC) development and response to therapy using a combination of mouse genetics, primary human tumors, and molecular, biochemical, and genomic approaches. A better understanding of intra-tumoral heterogeneity and of the driving factors in SCLC metastasis will instruct the development of novel therapeutic approaches to target the most lethal form of lung cancer.